Professional Development Core

ABSTRACT - Professional Development Core
Prevailing approaches for training the next generation of researchers in kidney, urologic, and hematologic
(KUH) diseases are not sustaining a vibrant and diverse workforce. Consequently, clinical care strategies for
patients with KUH diseases have remained stagnant despite rapid technological advances in bioengineering,
molecular biology, and genetics.
The Northwest COmprehensive Research Training in Kidney, Urologic and Hematologic Sciences (NCOR-
KUH) Program will integrate research trainees across KUH disciplines and foster their success in a scientific
research career. This Professional Development Core will create an immersive educational environment that
will support trainees in the NCOR-KUH Program, the faculty mentors of trainees, and students participating in
outreach programs. To address this goal, this Core will create a set of scientific and career development
conferences and research resources designed to meet the needs of individual trainees and attain core
competencies for success in a biomedical research career. Programs will include integrated KUH conferences,
biostatistical consultation, individual coaching in scientific writing and career skills, a small grants program,
entrepreneurship training, and opportunities to select elective additional courses in leadership skills.
This Professional Development Core will also create a contemporary mentor training program for faculty
mentors and a specialized KUH educational series for students and residents engaged in outreach programs
to stimulate their interest in a scientific research career. All activities will be hosted on a centralized online
platform to provide access to educational resources anywhere at any time.

Public health relevance
This Professional Development Core will create an immersive educational environment to support trainees, the faculty mentors of trainees, and students participating in outreach programs of the Northwest COmprehensive Research Training in Kidney, Urologic and Hematologic Sciences (NCOR-KUH) Program. This Core will develop scientific conferences and research resources designed to meet the needs of individual trainees and bolster their scientific and career progress.